Chromatin-mediated mechanisms of genome integrity

Abstract
Our research is focused on elucidating the mechanisms by which the local chromatin environment inﬂuences DNA-
templated processes including DNA replication, transcription and DNA repair. While considerable progress has
been made in our understanding of the mechanisms that direct DNA replication in vitro, we know very little about
how start sites of DNA replication (origins) are selected and regulated in the context of the chromosome. The
genomic approaches that my research group have pioneered have provided new insights into the mechanisms
by which the local chromatin state and structure (nucleosome and transcription factor occupancy) inﬂuences key
steps in regulating the DNA replication program in multiple species including S. cerevisiae and Drosophila. We
have recently developed a novel approach to `footprint' a eukaryotic genome – simultaneously revealing genome-
wide occupancy of DNA for both nucleosomes and smaller DNA binding factors (e.g. initiation and transcription
factors). Unlike biochemical reconstitution experiments utilizing one or two deﬁned DNA templates, we are able to
comprehensively view the cell cycle regulated cascade of chromatin changes that occur surrounding each origin
of replication in the yeast genome. Our future research will focus on identifying and characterizing the chromatin
mediated events required for initiation of DNA replication following helicase loading. We will also investigate how
chromatin structure is re-established throughout the genome to preserve epigenetic integrity following passage of
the DNA replication fork. DNA replication is also a potent source of double-stranded breaks (DSB) which, if not
repaired, may lead to genomic instability. We are uniquely positioned to identify and understand the dynamics
of chromatin structure following the induction of site-speciﬁc DSBs and their subsequent repair by homologous
recombination or non-homologous end joining. Finally, in collaboration with the Hartemink laboratory (Duke, CS)
we are using synchronous populations of yeast proceeding through the cell cycle to develop robust statistical ap-
proaches that will enable us to model cell cycle-dependent changes in gene expression from chromatin occupancy
data.

Public health relevance
Narrative All DNA-templated processes including transcription, DNA replication, and recombination and repair must occur in the context of the local chromatin environment. Failure to properly establish and regulate these DNA-templated processes may lead to genomic and epigenetic instability and potentially tumorigenesis.